GATING AND INHIBITION IN SCHIZOPHRENIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To identify subgroups of schizophrenia patients based on the convergence and divergence of the 4 inhibitory measures (PPI, P50 suppression, startle habituation, and the antisaccade task).